Training in Investigative Dermatology

PROJECT SUMMARY
This T32 competitive renewal application from the Yale Department of Dermatology proposes to continue its
strong track record of training future leaders in academic dermatology. Of the 32 trainees who were
supported by this T32 program during the past 15 years of funding and who have completed their
subspecialty and/or research training, 22 (>60%) are currently in full-time academic positions, and 13 are
actively engaged in substantive basic and/or clinical investigation, while 9 others are full-time clinician-
educators at Yale, Harvard, Stanford, Northwestern, and OSHU. Emphasis will be maintained on this program
developing the research and critical thinking skills of MD and MD/PhD dermatologists, although PhD
candidates with significant potential to make substantive contributions to translational and molecular
cutaneous biology will also be sought out for consideration. We also propose in the next period to capitalize
upon the experience of our faculty in training talented MD/PhD and PhD pre-doctoral students who now
populate T32 training programs across the country, including our own. The currently identified training faculty
for this renewal consists of thirty-two individuals with broad-ranging expertise in cutaneous biology and
substantive previous mentoring experience. 27 are R01-funded “Primary Mentors/Preceptors” (8 with faculty
appointments in Dermatology and 19 with appointments in nine other departments). All are established
mentors and conducting cutting-edge research collectively encompassing a substantial portion of cellular and
molecular biology. However, trainees are not restricted to these currently identified mentors as research
project preceptors; they are strongly encouraged to look broadly throughout the university for mentors whose
laboratories would provide them with the best opportunities to further develop and refine their research and
critical thinking skills. Qualifications for being a primary mentor include current R01 level sfunding, a
documented previous track record as a successful mentor, and approval by this program's Executive
Committee. Because we consider it most conducive to the trainees' development of intellectual independence
and to the introduction of new scientific skills into dermatology, substantial exposure to outstanding
investigators outside our own department will continue to be emphasized. As in past funding periods, each
trainee will have two mentors, one inside and one outside of Dermatology. Typically, the Primary Mentor/PI is
based is outside the department, and the Dermatology faculty secondary advisor serves as an additional
monitor of the trainee's progress to help ensure that her/his career trajectory stays on course. 17 Dermatology
faculty members have been designated as potenital “Secondary Mentors/Advisors” including physician-
scientists as well as those that are principally clinically oriented or have yet to fully establish their indendent
research programs. 4 individuals have been identified as junior faculty with demonstrated abilities to obtain
peer-reviewed funding and outstanding potential to become primary mentors within the next funding cycle.

Public health relevance
PROJECT NARRATIVE The relevance of this grant proposal to public health lies in the fact that it is directed at training talented young investigators including physicians (MDs or MD/PhDs), talented MD/PhD or PhD predoctoral candidates, and PhD investigators to ultimately enter full-time academic careers in basic and/or clinical research and teaching in dermatology, thereby increasing our understanding of cutaneous (skin) biology, and our ability to more effectively treat a broad variety of skin diseases. The public health impact of skin disease is significant, with inflammatory disorders such as highly prevalent atopic dermatitis and psoriasis causing significant morbidity, and cutaneous malignancy causing both morbidity and mortality. It is critical to train new generations of skin disease researchers to more develop new approaches to diagnosis and treatment of such disorders.